Regulatory mechanism of novel host-relevant biofilm formation protein in non-Cholera Vibrio species

PROJECT SUMMARY/ABSTRACT
Non-cholera Vibrio (NCV) species represent a notable and increasing threat to human health and food safety.
The biofilms formed by Vibrio species are robust and highly relevant to host infection. Biofilms are tightly
regulated communities of matrix-associated bacteria and are a major component of bacterial pathogenesis
including drug resistance. Since an estimated 75% of bacterial infections involve biofilms, it is crucial to better
understand how biofilms are formed. In this application, I propose to elucidate the molecular mechanism of an
unusual regulatory protein necessary for controlling NCV biofilm formation. This protein is conserved in NCVs
and controls the production of symbiosis polysaccharide (Syp), a component of the biofilm matrix involved in
host infection. Based on preliminary findings, this protein has an atypical mode of action compared to well
characterized homologs. My fundamental hypothesis is that this NCV biofilm regulator protein uses a novel
mechanism to control biofilm formation and will challenge our current understanding of this family of proteins.
My hypothesis will be addressed through two specific aims: 1) probing the protein’s function using biochemical
and structural characterization studies, and 2) uncovering its position in the regulatory network by identifying
binding partners. The proposed research is innovative because it focuses on a system that is crucial for biofilm
formation, and to date, the system has only been investigated using cellular and genetic approaches. The
structure-function approach proposed here will provide essential information needed to fill our knowledge gaps.
The project is significant because it will provide a deeper understanding of the regulation of host-associated
biofilms from the rising threat of NCV infection. Ultimately, the work proposed will answer key questions related
to the molecular mechanisms of a protein within a critical and conserved pathway that regulates host-relevant
biofilms. Support from this K22 award will facilitate my transition to an independent investigator by providing me
with resources to generate data and publications that will strengthen my competitiveness for future funding.

Public health relevance
PROJECT NARRATIVE Non-cholera Vibrio species are a significant threat to human health through food poisoning and wound infection exacerbated by biofilms. This project will use structural and biochemical techniques to probe a central component of a highly relevant biofilm regulatory pathway. The resulting information will provide us with greater insight into the mechanisms governing this system and advance the field by broadening our understanding of how bacteria regulate biofilm formation.